Novel Selective Type II kinase Inhibitors to treat Diabetes

Project Summary: Both Type 1 and 2 diabetes result from reductions in pancreatic -cell mass and function.
Thus, a major goal of the NIH/NIDDK is to develop novel drugs and tools that can lead to replacement and/or
regeneration of human -cells. This is has proven difficult, because adult human -cells are refractory to
engagement in cell cycle progression. This project is in response to PAR16-121 to extend the level of early
stage pharmacological validation of novel targets, novel chemical scaffolds that are not the focus of significant
efforts in the biotechnology and pharmaceutical industry for treatment of diseases within the mission of the
NIDDK. The goals of this proposal align well with these objectives and specific areas of interest including
medicinal and computational chemistry, structural biology and pharmacological validation of novel targets for
diabetes. Specifically, we have recently reported in Nature Medicine in 2015 that a type I DYRK1A kinase
inhibitor activates both rat and human β-cell replication at rates that approach those required for therapeutic
human β-cell replication. This work was published and confirmed by other labs.
We envision three components to exploiting these results: A, Optimization of DYRK1A inhibitors for
beta cell proliferation since there are NO known compounds of this class in clinical development; B, Tissue
Specific Targeting to pancreatic beta cells currently underway in our labs funded by NIDDK grant (R01
DK015015-01-A1); C, Understanding the effects of the immune system on newly replicated beta cell which can
only be addressed after successfully completing components A and B.
Current known DYRK1A inhibitors target the type I ATP-binding pocket of kinases and have significant
liabilities for further drug development. Our premise is that novel leads, developed for the specific use for β -
cell proliferation will provide further validation of this target of interest to NIDDK. Our strategy of kinase
optimization coupled with powerful phenotypic assays will lead to improved inhibitors. To that end, we have
identified novel drug-like leads that target the inactive kinase (DFG-out type II kinase inhibitors). These results
provide the basis for a drug discovery effort that includes a molecular target, in vitro/in vivo β-cell biology, and
viable starting points for medicinal chemistry optimization. In this application, our experienced team of β-cell
biologists, computational and medicinal chemists will pursue three translational Specific Aims:
Specific Aim 1. Develop two novel, structurally distinct type II DYRK1A inhibitors with kinase/off-target
selectivity and oral bioavailability for β-cell proliferation using structure-based drug design.
Specific Aim 2. Evaluate these novel compounds for inhibition of DYRK1A, β-cell proliferation and
function, optimized kinase and off-target selectivity profiles using biochemical and cell-based assays.
Specific Aim 3. Evaluate optimized DYRK1A inhibitors for in vivo ADME PK, efficacy using animal
models of reduced β-cell mass, diabetic animal models and their safety profiles in normal rodents.

Public health relevance
Project Narrative In this proposal, we will use medicinal chemistry, biology and pharmacology to optimize and develop novel, selective, type II DYRK1A kinase inhibitors with human -cell proliferative activity and characterize them using in vitro and in vivo assays. The results of this research are expected to provide compounds to use in safety and chronic efficacy studies. Optimized small molecules may also be used for tissue targeting strategies necessary for translation to human clinical studies of this promising new approach to cure diabetes. These studies are directly relevant to the 2.5 million people in the US with type 1 diabetes (T1D), the 30 million with type 2 diabetes (T2DM), and the 347 million people globally with diabetes, all of whom will benefit from therapeutic approaches to expand -cell mass and function.